Biochemistry Core

1. Core utilization and accomplishments - A total of 47 people from 22 laboratories have used for the facility services and instruments. - Support investigators by implementing methods for 1) mass measurement of intact proteins and organic compounds (a total of 2,417 samples from 18 laboratories), and 2) separation and quantification of proteins or metabolites by HPLC (a total of 731 samples from 8 laboratories). - Applying a new method for the quantification of small organic compounds by LC-MS and development of a new sample preparation method to speed up data collection. 2. Core publications 1) Liu, Y., et al., The PPR domain of mitochondrial RNA polymerase is a ribonuclease required for mtDNA replication. bioRxiv, doi: https://doi.org/10.1101/2021.03.12.435139 (2021) 2) Morris, DL., et al., Humanin selectively prevents the activation of pro-apoptotic protein BID by sequestering it into fibers. J. Biol. Chem. 295, 18226-18238 (2020) 3) Chen, J., et al., -tubulin tail modifications regulate microtubule stability through selective effector recruitment, not changes in intrinsic polymer dynamics. Dev. Cell 56, 1-13 (2021) 4) Huang, T., et al., Microfibrous extracellular matrix enhances in vitro modeling of the liver hepatocytes by modulating metabolism and integrin expression. Material Science doi: 10.26434/chemrxiv.11739312.v1 (2021) 5) Mahalingan K., et al., Structural basis for polyglutamate chain initiation and elongation by TTLL family enzymes. Nat Struct Mol Biol. 27, 802-813 (2020) 6) Dean, D., et al., Defining an amyloid link Between Parkinsons disease and melanoma. Proc Natl Acad. Sci U S A. 117, 2267122673 (2020) 7) Hickman A., et al., Casposase structure and the mechanistic link between DNA transposition and spacer acquisition by CRISPR-Cas. Elife 9, e50004 (2020) 8) Aguilar-Cuenca, R., et al., Tyrosine Phosphorylation of the Myosin Regulatory Light Chain Controls Non-muscle Myosin II Assembly and Function in Migrating Cells. Curr Biol.30, 2446-2458 (2020) 9) Uchida, N., et al., Preclinical evaluation for engraftment of CD34+ cells gene-edited at the sickle cell disease locus in xenograft mouse and non-human primate models. Cell Rep. Med. 2, 1-11 (2021) 3. New instrumentation and new services - Replacement of the old HPLC modules (binary pump and DAD) with a new modules: Improved system performance and connectivity between modules and PC. - Measurement of the DNA oligonucleotides using the LC/MS. - Quantification of specific metabolites by LC-MS (N-arachidonyl glicine, etc.). 4. FY202 budget Budget spent 99.9% as of August 23, 2020. - Maintenance contract for LC/MS---- 80% - Solvents and chemicals------------ 15% - General consumables---------------- 5%